Physical Activity Platform to Improve Bone Health in Cancer Survivors

ABSTRACT Cancer treatment-induced bone loss and the subsequent risk of fractures in both men and women impacts not just survivors’ quality of life, but is also a significant burden on national health care. Clinical studies have reported that moderate-intensity resistance exercises prevent a decline in bone health in female cancer survivors, and that strength training may reduce complications associated with cancer such as fatigue, muscle wasting, and bone loss. Unfortunately, only a small percentage of women who have had cancer, engage in and adhere to a strength training exercise routine. We have developed a internet-based application, ThrivorsTM, that guides cancer survivors through exercise routines with light-to-moderate strength training in the home setting, and connects them to survivorship resources. In this Phase I proposal, we will develop and deploy an enhanced version, Thrivors+BHTM, that disseminates resistance training exercises specifically impacting bone health (BH), integrated with video-based interactive feedback and tracking of adherence to exercise routines. Our goal is to validate Thrivors+BHTM as a novel tool to bridge the gaps between cancer survivorship, physical activity, value-based care and health care organizations (providers and payers), to positively impact bone health in breast cancer survivors.

Public health relevance
NARRATIVE There is an unmet need for improving adherence to bone health-specific exercises among cancer survivors who are at increased risk of fractures due to cancer treatment-induced bone loss. We are developing Thrivors+BHTM, an internet-based survivorship care technology platform that empowers cancer survivors to self-improve their bone health, and self-manage secondary conditions impacting their quality of life. We anticipate that Thrivors+BHTM will be a cost-effective tool for bridging the gaps between cancer survivorship, physical activity, value-based care, and health care providers and payers.